Development of Dual Efficacy Therapeutic Against Cryptosporidiosis and Giardiasis

Project Summary/Abstract The potential for devastating consequences of cryptosporidiosis or giardiasis diarrhea in immunocompromised patients and malnourished children emphasizes the need for an effective therapy that could be used syndromically as a single agent appropriate for administration where diagnosis may be delayed or uncertain. This is also true for asymptomatic presentations of both diseases that can be devastating. The etiologic parasites colonize and reproduce in the small intestines of mammalian hosts where they are associated with microvilli of the epithelial cells. Hence, potential for finding dual therapeutic is high based on common anatomical site of infection. Protein kinase inhibitors have attracted considerable attention as potential therapeutics since a number of them have been released as drugs in recent years and many are in various phases of clinical trials. In a semi High throughput screening of MMV Pathogen box, we demonstrated that dual hitting molecules including kinase inhibitors with no obvious chemical similarity with any previously characterized anti-parasite drugs offer new medicinal chemistry opportunities for development of effective multi-parasite therapeutics against cryptosporidiosis and giardiasis. This research proposal capitalizes on the unique preliminary findings to hypothesize that effective single agent therapy that could be used syndromically for treatment of either cryptosporidiosis or giardiasis is possible. In Years 1-2 (R21 phase): we will screen for, select and optimize dual effective hits to early leads. In Specific Aim 1a ? we will determine in vitro efficacy of ~2000 unique chemical scaffold inhibitor clusters in blocking parasites growth using direct phenotypic screening. We will select up to 50 hit scaffolds by rank order of efficacy against parasites and potential for mammalian cytotoxicity. In Specific Aim 1b ? we will screen analogs of each of the 50 hit scaffolds identified in Aim 1a to develop structural activity relationship. Criteria for moving forward will include parasite killing efficiency, either static vs. cidal, selectivity, and ease of medicinal chemistry development. In Specific Aim 2 we will use stability in simulated gastric/intestinal fluids, pharmacologic and pharmacokinetic studies to identify ~20 effective early lead for both species and confirm clinical efficacy in mouse infection models. In Years 3-5 (R33 phase): We will do lead optimization for efficacy, selectivity, and PK/ADMET properties under Specific Aim 3 - Medicinal chemistry; pharmacokinetic studies, in vitro compound efficacy, pharmacology, toxicity and resistance. In the final part of the project under Specific Aim 4 - In vivo compound efficacy and resistance, optimized leads will be evaluated for clinical efficacy in the mouse infection models and determine potential ease of developing acquired resistance and fitness cost of resistance to compounds being investigated. The product of this research study would be useful as parasitic diarrheal therapeutic with the potential for broad spectrum activity. It will have significant public health benefits in many developing regions of the world.

Public health relevance
Project Narrative The ultimate goal is to discover a kinase inhibitor that could be developed as an oral multi parasite effective therapeutic against cryptosporidiosis and giardiasis diarrhea with potential usefulness in other intestinal parasitic diseases. We will use high-throughput drug screening of about 50,000 kinase inhibitor libraries as the basis for the project. The common anatomical site of the diseases, should aid in finding a dual use drug because of similar pharmacokinetic (PK) and pharmacodynamic (PD) requirements for a therapeutic.